Proteogenomic translator for cancer biomarker discovery towards precision medicine

PROJECT SUMMARY
The goal of this Supplement Application is to enhance the proteogenomic integrative analysis for CPTAC/CCDI
pediatric brain tumor studies. Towards this goal, our First Aim is to apply multiomics and network-based
system learning to reveal causative molecular regulatory relationships contributing to the varieties of
phenotypes in cancer using the CPTAC/CCDI proteogenomic data. We will construct protein/PTM causal
networks based on global-, phospho-, glyco-, and other PTM-proteomics data. When constructing these
networks, we will use and extend advanced computational tools to effectively borrow information from the
published literature, publicly available open databases, and transcriptomics profiles. Furthermore, we will
leverage iProMix, a cell-type-aware association test tool, to isolate regulatory interactions active within tumor
cells, filtering out confounding signals from the microenvironment and refining clinically translatable targets.
Our Second Aim is to
through
proteogenomic
normal
literature
heterogeneity
kinase
Search)
preclinical
analysis,
nominate novel protein-based cancer biomarkers, drug targets, and therapeutic compounds
a multi-faceted approach. Under Aim 2.1, the Multiomics2Target platform will be expanded to analyze
data f rom CPTAC-CCDI-KidsFirst, comparing protein and mRNA expression in tumors versus
brain tissues. Targets will be prioritized using brain-derived cell line data (DepMap, CCLE), validated through
review and AI/ML-driven functional predictions. Aim 2.2 focuses on identifying drivers of tumor
by leveraging the ChEA-KG and KEA-KG tools to map transcription-factor regulatory modules and
subnetworks, elucidating their roles in tumor subtypes. Moreover, Aim 2.3 mploys (LINCS L1000 Signature
L2S2 and DRUG-seqr (utilizing Novartis's DRUG-seq published datasets) to prioritize approved drugs and
small molecules capable of halting tumor proliferation. Together, these strategies integrate multiomics
regulatory network modeling, and drug discovery platforms to advance targeted therapeutic interventions.
e
Finally, for all analysis tasks in Aim 1 and 2, we will derive an integrated view of commonalities and differences
across multiple tumor types via Pan-Cancer analyses as outlined in the Third Aim.

Public health relevance
PROJECT NARRATIVE The goal of this supplement is to enhance the integrative proteogenomic analyses for CPTAC/CCDI pediatric brain tumor studies. We will elucidate the regulatory molecular and cellular complexity underlying tumors by employing multiomics and network-based systems learning on proteogenomic data. The project will generate valuable resources including: (1) high-confidence candidate biomarkers and drug targets; (2) new knowledge of cancer biology that involves integrated genomics, transcriptomics, and proteomics; and (3) new bioinformatics tools that will aid in the mining, visualization, and interpretation of large-scale and complex cancer-related datasets.